Northwestern Center for Reproductive Science Predoctoral Training Program in Reproductive Science, Medicine, and Technology

The Northwestern Center for Reproductive Science Predoctoral Training Program in Reproductive Science,
Medicine, and Technology (CRS Training Program) will train future leaders in the reproductive sciences, while
simultaneously improving human health. Over the 5-years of the CRS Training Program, we will train a total of
27 predoctoral students (in two year cohorts). These trainees will come from 6 of Northwestern's top graduate
programs in the life sciences, chemistry, bioengineering, and medicine. Our freshly minted doctorates will enter
the professional arena at an unusual time for science – one marked by low funding and fierce job competition.
Therefore, we have designed a comprehensive educational paradigm with a focus on cutting edge and emerging
technologies that will create successful leaders in reproductive science and across multiple disciplines in this
lean, face-paced environment. Our trainees will receive well-rounded training in reproductive science and
medicine through coursework spanning didactics on basic and clinical male and female reproductive physiology,
reproductive technologies laboratory skills, research proposals and scientific communication, and responsible
conduct of research. Our 20 CRS Training Program Mentors come from 12 departments and study reproductive
science and medicine from basic, translational, and clinical perspectives. This diversity is complemented by a
common emphasis on technological advances, as all mentors are either inventors or use new technologies to
solve the largest unanswered questions in infertility and fertility, infectious diseases, reproductive tract diseases,
and cancer. Trainee coursework and laboratory training will be bolstered by unique CRS Training Program
experiences. All trainees will participate in Academic Accelerator Partnerships, which are extended laboratory
and core facility exchanges, short courses, or externships designed to expose students to team science and the
latest technologies related to their dissertation research. Trainees will also receive formalized professional and
career development upskilling through our Career Catalyst Series which exposes our trainees to diverse career
opportunities and prime them with the necessary career skills, including communication (written, oral, visual),
self-assessment, networking, teamwork, and outreach. Our CRS Training Program is embedded in the Center
for Reproductive Science (CRS), which has a four-decade history of keeping reproductive science and medicine
visible, viable, and valuable. The CRS infrastructure will provide a physical space for our trainees and an
intellectual hub of data clubs, seminars, workshops, and summits. Reproductive health is all-encompassing, and
our program incorporates diversity across the spectrum - from our trainees, to our mentors, and to our outreach
communities. Ultimately, this ambitious but tangible CRS Training Program will provide trainees with the most
comprehensive formal training in our field; this coupled with the enthusiasm of our outstanding faculty and the
career catapulting technologies that can be brought to bear on the critical questions of our field together represent
the keys to successful training in reproductive science.

Public health relevance
Project Narrative: Reproduction is essential for life and provides a window into overall health. The Northwestern Center for Reproductive Science Predoctoral Training Program in Reproductive Science, Medicine, and Technology (CRS Training Program) will support and train a sophisticated workforce in reproductive science and medicine who will make the discoveries necessary to enable a healthy future for all people. We will do this by combining rigorous didactics and bench research with training opportunities in the technologies of the future, generating a new kind of scholar who can succeed in a fast-paced, competitive scientific environment.